Investigating the role of SIRT3 in metabolic flexibility and proteostasis in the aging heart

Cardiovascular disease is the leading cause of death in the United States and its occurrence dramatically
increases with age. Preventing or delaying cardiac aging can therefore have a significant effect on longevity and
healthspan. A central goal of this proposal is to explore a novel mechanism by which mitochondria decline with
age and contribute to loss of cardiac function. We are focusing on the post-translational modification, acetylation,
because it increases with age and the enzyme that reverses this modification, sirtuin-3 (SIRT3), is a known
longevity factor that decreases with age. However, if mitochondrial acetylation accelerates cardiac aging remains
unresolved and controversial. Our overarching hypothesis is that an increase in acetylation has two effects in
the aged heart. First, it causes metabolic inflexibility by directly affecting the activity of key regulatory enzymes.
Second, the increase in acetylation affects proteostasis (protein synthesis and degradation homeostasis).
Dysfunctional proteostasis in turn contributes to metabolic inflexibility by causing improper synthesis and
degradation of modified mitochondrial metabolic enzymes. For this proposal, we generated a cardiomyocyte
(CM) specific SIRT3 knockout mice (SIRT3CM-/-). Our preliminary data show that SIRT3CM-/- mice exhibit dramatic
hypertrophy, loss of contractile function, fibrosis, metabolic abnormalities, and dysfunctional proteostasis by 10-
months. This accelerated model of aging and hyperacetylation will be used to test our hypothesis through the
following aims. Aim 1 will determine if the increase in acetylation caused by the loss of SIRT3 affects metabolic
flexibility with age. We hypothesize that the loss of SIRT3 causes metabolic inflexibility by affecting the activity
of discrete mitochondrial regulatory enzymes that result in the increased reliance on glucose. This aim will
determine if the loss of SIRT3 affects metabolic flexibility by measuring cardiac and mitochondrial functions,
enzymatic activities, and metabolic flexibility longitudinally in SIRT3CM-/- mice and isolated adult cardiomyocytes.
Global acetylation and the acetylation of specific metabolic enzymes will be measured by mass spectrometry.
The results of these studies will determine if there is a direct consequence of hyperacetylation on cardiac
pathology in the absence of SIRT3. Aim 2 will determine how the loss of SIRT3 affects mitochondrial
proteostasis. Acetylation of proteins can affect structure and function, yet little is known regarding its role in
global changes in mitochondrial protein quality and turnover. This aim will use deuterium oxide (D2O) labeling
and proteomics to determine if the loss of SIRT3 affects mitochondrial protein synthesis and the relative turnover
rates of specific metabolic regulatory enzymes. Rescue experiments will be performed by AAV delivery of SIRT3.
Mechanistic studies in cell culture will be performed to demonstrate how acetylation affects proteostasis. These
will be the first studies to employ in vivo labeling to determine how acetylation affects protein synthesis and
turnover. The results will provide an impetus for future projects further defining how acetylation and other carbon
stresses affect cardiac aging.

Public health relevance
The heart loses function with age and this is caused in part by changes in cardiac metabolism. We are examining how the modification of proteins within mitochondria affects metabolism and contributes to this loss of cardiac function. The results of the study will give us a better understanding of the aging process so that better intervention strategies can be developed.